Lateral line sensory nerve guidance by a migrating cell collective

PROJECT SUMMARY
The cochlear nerve, critical for hearing, relies on precise extension and connectivity during development.
Cochlear nerve deficiency (CND) is a congenital malformation resulting in an absent or small cochlear nerve that
leads to severe or profound hearing loss with permanent and detrimental effects on patient quality of life. To
better understand CND pathophysiology, the mechanisms guiding cochlear nerve development must be
understood. This project’s objective is to determine how the in vivo tissue environment impacts cochlear nerve
development, using the zebrafish posterior lateral line nerve (pLLN) as a model. Similar to processes in the
mammalian cochlea, the zebrafish pLLN extends alongside a migrating cell collective called the primordium. Our
hypothesis is that secreted signals from the primordium contribute to the dynamics of adhesive signaling in pLLN
development.
These mechanisms will be investigated in zebrafish by integrating in vivo imaging of fluorescently labeled growth
cones and primordium cells with genetic and experimental manipulations. In Aim 1, the role of specific adhesion
molecules in the co-migration of the pLLN and primordium will be characterized. Aim 2 will examine how the
location and timing of secreted cues impact pLLN extension and adhesion to the primordium. Lastly, Aim 3 will
focus on mapping the progressions in gene expression of neurons forming the pLLN and the cells of the
primordium over time as a way to evaluate the relative composition of intercellular signaling. These studies will
clarify how adhesive and secreted cues cooperate to ensure robust pLLN development, offering insight into the
developmental process of the cochlear nerve. Findings in these areas support the search for future therapeutic
targets for CND.
The described studies will be carried out under the direct mentorship of Dr. A. J. Hudspeth at The Rockefeller
University within the supportive Weill Cornell/Rockefeller/Sloan Kettering Tri-Institutional MD-PhD Program
environment. This fellowship constitutes an important career milestone for dual-degree students seeking to
become independent investigators.

Public health relevance
PROJECT NARRATIVE Cochlear nerve deficiency (CND) is a congenital malformation that results in severe or profound hearing loss with permanent and detrimental effects on patient quality of life. To better understand CND pathophysiology, investigation on the developmental process of the cochlear nerve in relation to its dynamic tissue environment is warranted. This study may elucidate future CND treatment targets by using a zebrafish model to investigate how secreted and adhesive cues from cellular neighbors guide sensory nerve development.